Prevention and treatment of paclitaxel-induced peripheral neuropathy

Chemotherapy-induced peripheral neuropathy (CIPN) is a debilitating condition with potentially
devastating effects on large numbers of cancer patients. According to the Centers for Disease Control and
Prevention, 650,000 patients are treated with chemotherapy every year in the United States, and between 30-
70% of these patients will develop symptoms of CIPN. Clinical research has demonstrated CIPN is a leading
cause of therapeutic non-compliance, reduced quality of life and poorer cancer survival rates. Patients who
develop symptomatic CIPN also have an associated $20,000 increase in overall treatment cost in comparison
to patients that do not develop symptoms and are also more like to suffer relapse of their cancer. Currently, there
are no established treatments for CIPN.
We propose that 4-aminopyridine (4AP), principally a K+ channel inhibitor, is a promising candidate to
prevent and/or treat CIPN. Separate from the known abilities of 4AP to enable impulse conduction in axons with
myelin damage, 4AP has recently been used to treat acute peripheral nerve injuries with enhanced durable
functional recovery and repair of myelin damage. In more recent studies, treatment of acute skin wounds with
4AP enhances healing and regeneration of neural elements of skin. In addition, in its best studied applications,
4AP is used to provide symptomatic relief in a variety of neurological syndromes in which normal nerve cell
function is compromised. Restoring normal nerve function may also be relevant to decreasing neuropathic pain,
as seen in previous studies in individuals with chronic spinal cord injury.
The over-arching hypothesis of this proposal is that 4AP can be used to prevent or decrease
caused by exposure to paclitaxel (PTX). Our experiments will test the independent sub-hypotheses that (i)
initiation of 4AP treatment prior to establishment of CIPN prevents its development without compromising the
effectiveness of PTX in treating a well-accepted syngeneic model of breast cancer in mice; and (ii) established
CIPN is responsive to 4AP as a means of decreasing neuropathic pain after CIPN is established.
An established mouse model for PTX-induced CIPN will be used in these experiments. 4AP will be
studied both as a concurrent treatment with PTX to prevent CIPN development, and as a means of providing
symptomatic relief in established CIPN. Outcomes will evaluate the pressure sensitivity (allodynia), thermal
sensitivity, gait coordination, electrophysiology, muscle physiology, and histology focusing on the ultrastructural
changes.

Public health relevance
Up to 70% of the 650,000 of cancer patients treated with chemotherapy will develop chemotherapy induced peripheral neuropathy (CIPN) that results in poor compliance, decreased quality of life, higher recurrence rates, and increased healthcare costs. Despite advances in therapeutic agents, paclitaxel remains one of the primary treatments of choice in hormone resistant breast cancer yet it continues to induce one of the highest incidences of CIPN. As there are currently no effective treatments for CIPN, the over-arching hypothesis of this proposal is that we have discovered that an existing drug used in treatment of other conditions, can be used to decrease or prevent CIPN caused by treatment with paclitaxel.